Multi-Omics DACC: The Data Analysis and Coordination Center for the collaborative multi-omics for health and disease initiative

ABSTRACT
The NIH is establishing a new Multi-Omics for Health and Disease Consortium to advance the application of
multi-omic technologies to study health and disease in ancestrally diverse populations. The Consortium
comprises three components: Disease Study Sites (DSSs), ‘Omics Production Centers (OPCs), and a Data
Analysis and Coordination Center (DACC). The project aims to establish a DACC to coordinate and support
the Consortium’s activities and maximize its success. To be impactful, the Consortium’s experimental protocols
must be transparent and reproducible, data must adhere to the FAIR guiding principles (Findable, Accessible,
Interoperable, Reusable), and computational methods and software tools must be open to the public.
Furthermore, an interactive portal is needed for intuitive access to the data, and dedicated outreach efforts are
required to assist the community in data use. We have assembled a unique team of investigators, data
wranglers, software engineers, bioinformaticians, and postdocs to form a DACC to meet the challenges of
ensuring high data quality and maximizing the consortium’s impact. All five DACC investigators have held
leadership positions in large consortia in the past decade and bring substantial expertise in data coordination,
management, harmonization, analysis, and integration. Our DACC will accomplish the goals of the Consortium
via six specific aims: Aim 1. Coordinating and contributing to Consortium-wide protocol development, data
analysis, and methods development. Aim 2. Managing and securing Consortium data by specifying metadata,
establishing submission processes and standards, and incorporating experimental data and analysis results
into AnVIL. Aim 3. Creating a multi-dimensional dataset that is available to the broader research community.
Aim 4. Designing, developing, and maintaining an open-access portal for cataloging, querying, and visualizing
summary-level data. Aim 5. Coordinating consortium logistics by organizing and facilitating internal and
external activities, communications, and collaborations. Aim 6. Coordinating community outreach and
dissemination of Consortium findings.

Public health relevance
NARRATIVE The NIH is establishing a new Multi-Omics for Health and Disease Consortium to apply multi-omic technologies to study health and disease in ancestrally diverse populations. This project aims to establish a data analysis and coordination center to coordinate and support the Consortium’s activities and maximize its success. The center will manage consortium data, coordinate and contribute to protocol development and data analysis, create a multi-dimensional dataset and a data portal, and provide outreach to disseminate consortium results.